Evolutionary Diversification of Cytoskeletal Proteins for Tissue-Specialized Roles

Project Summary/Abstract
Cytoskeletal proteins perform essential roles in cell biology, and they generally evolve under stringent sequence
conservation across phyla for these functions. One cytoskeletal family known as the actin-related protein (Arp)
superfamily evolved before the last common ancestor of eukaryotes and plays many fundamental roles in the
cytoplasm and nucleus, including nucleating actin, transporting cargo, repairing DNA damage, and chromatin
remodeling. Most studies of Arps are motivated by their ubiquity and stringent conservation. However, we have
discovered that the Arp superfamily displays unexpected diversification via the rapid expansion of paralogs and
accelerated amino-acid substitutions in Drosophila and mammals. Interestingly, this genetic diversification
across phyla has acquired tissue-specific expression and is often enriched in the male germline, a striking
contrast to the ubiquitously expressed canonical Arps. Arp diversification is largely unexplored relative to studies
of almost universally conserved Arps, most likely due to the lack of deep evolutionary roots. However, rapid
sequence divergence suggests functional innovation that provides a fitness advantage and raises questions
regarding how Arp diversification has specialized for tissue-specific roles. All Arps share the canonical actin fold,
and accumulating evidence indicates that recent Arp adaptation has repurposed the actin fold for critical
functions in fertility and development and may play unique roles in actin biology. We will gain molecular insight
into this unexpected diversification of Arps in Drosophila and mammals to reveal how it specializes cytoskeletal
networks for specific cellular contexts. Here, we outline our research program over the next five years, focusing
on three distinct projects investigating Arp diversification in insects and mammals. We will determine how
evolution alters the canonical Arp2/3 complex, an essential actin nucleator found in most eukaryotes, and tailors
actin polymerization kinetics, stability, and structure for tissue- and species-specific actin networks. Additionally,
we will investigate a young, non-canonical Arp that arose in flies and plays a role in fertility. Studying this
Drosophila Arp provides a unique opportunity to genetically dissect how evolution modified the actin fold for
novel functions without comprising actin’s essential roles. Lastly, we will focus on several non-canonical, rapidly
evolving Arps in mammals that form a complex, localize to actin in the testis, and are critical in shaping the sperm
head. We will identify how these divergent Arps adapted for complex assembly and gain structural insight, which
will shed light on how mutations in these Arps lead to human infertility. Overall, this proposal uses an
interdisciplinary approach, including cell biology, genetics, and biochemistry, to understand from a molecular to
an organismal level how Arps across phyla evolve and functionally innovate for specialized roles. Our long-term
goal is to extend our analyses to other cytoskeletal families that display unique evolutionary diversification to
broadly study the roles of cytoskeletal proteins beyond core “housekeeping functions” and reveal how these
proteins unexpectedly adapt and fulfill roles their canonical counterparts fail to accomplish.

Public health relevance
Project Narrative Cytoskeletal proteins play fundamental roles in numerous biological processes in all eukaryotes. However, many cytoskeletal proteins, including Actin-related proteins (Arps), are subject to accelerated diversification in the form of gene duplications and rapid sequence changes across phyla. This proposal investigates how cytoskeletal proteins, primarily Arps, undergo adaptation and innovate, rather than conserve function, for tissue-specific roles that impact fertility and development.